Development and Implementation of a Culturally Centered Opioid Prevention Intervention for American Indian/Alaska Native Young Adults in California

PROJECT SUMMARY/ABSTRACT
American Indian/Alaska Native (AI/AN) people are disproportionately affected by the opioid epidemic. They
have the highest rates of diagnosis for opioid use disorders (OUD) and deaths from drug overdose. The COVID-
19 pandemic dramatically changed how health interventions are delivered within the healthcare setting, and we
had to change our new opioid use prevention intervention for urban AI/AN emerging adults to virtual at the
beginning of the pandemic. Although we have been successful in recruiting individuals from 28 states into our
study and having these individuals complete surveys, we have encountered challenges with retention in the
online workshops as the pandemic has progressed. As COVID-19 rates began to decrease, our emerging adult
population began to re-engage more with recreational, social, education, and employment activities, and
participation and retention in the workshops decreased. We thus pivoted once again to increase both feasibility
and deliverability of Traditions and Connections for Urban Native Americans (TACUNA) by decreasing our
workshops to 1-hour, recognizing realities of zoom fatigue and the busy and active lifestyles of our study
population. The aims of this supplement are within scope of the parent grant, yet expand the grant by
providing us with a unique opportunity to analyze and compare benefits of deliverability of the virtual 1-hour
workshops with our originally planned 2-hour workshops. We have 158 participants who were assigned to the
2-hour TACUNA program. This supplement will allow us to obtain an additional 50 participants for the 1-hour
TACUNA program, so we can obtain a total N= 75 in this new condition. Aim 1. Assess differences between the
virtual 1-hour version of TACUNA and the 2-hour version of TACUNA on the main outcomes of the parent
grant at 3-, 6- and 12-months: initiation and escalation of opioid use and alcohol and other drug use, such as
marijuana, and related consequences; time spent around peers who use opioids and alcohol and other drugs,
and perceived prevalence of peer use. Aim 2. Examine whether overall participation and retention differs
between the virtual 1-hour TACUNA and 2-hour TACUNA. Aim 3. Examine whether there are differences on
both quantitative and qualitative satisfaction between the virtual 1-hour TACUNA and 2-hour TACUNA using a
mixed methods analysis. This is the first study to evaluate effects of procedural changes that had to be made
due to the COVID-19 pandemic, specifically by comparing opioid, alcohol and cannabis outcomes for urban
AI/AN emerging adults who receive 1-hour virtual TACUNA workshops compared to those who receive 2-hour
workshops. There is great potential to demonstrate how TACUNA can meet the needs of the tribally-diverse
and heterogeneous population of AI/AN emerging adults residing in urban and other non-reservation areas
throughout the U.S. This study will also provide critical information on how participants view the two versions
of these virtual workshops using a mixed methods approach.

Public health relevance
Narrative Data show that American Indian/Alaska Native (AI/AN) people have the highest rates of diagnosis for opioid use disorders (OUD) and deaths from drug overdose, yet there are no prevention programs addressing opioid misuse among urban AI/AN young adults that integrate culturally appropriate strategies with evidence-based treatment. This supplement is focused on understanding whether outcomes, participation, retention, and satisfaction differ for participants who received a virtual 2-hour program compared to those who received a virtual 1-hour program. Findings will provide a better understanding of how TACUNA can help decrease effects of the opioid epidemic among urban AI/AN people.